Longitudinal Study of Health and Ageing in Kenya (LOSHAK)

The proposed project aims to build the infrastructure needed to successfully field the Longitudinal Study of Health
and Ageing in Kenya (LOSHAK), a population-based cohort study of adults age ≥45 years in Kenya. This will be
a new study in the Health and Retirement Study (HRS) network of harmonized studies on aging. Key focus areas
of LOSHAK will include Alzheimer’s disease and related dementias (ADRD), mental health, the health and
economic impacts of climate change and air pollution, and factors influencing late-life economic well-being.
Kenya currently has a relatively young population, but is poised to experience very rapid aging of its population
over the next 30 years. Accordingly, it is vitally important to begin studying both population-level trends, as well
as individual aging trajectories in order to characterize risk factors for health, disability, and well-being in the
Kenyan context. Importantly, there is a major gap in population-level data on aging in Sub-Saharan Africa, and
LOSHAK will be only the second study in the HRS Network from the region. In order to carry out the proposed
infrastructure development aims, we will leverage our study team’s ongoing epidemiologic surveillance platform,
the Kaloleni/Rabai Community Health and Demographic Surveillance System (KRHDSS) in coastal Kenya,
which includes more than 14,000 individuals age ≥45 years. In this application we propose the following aims:
1) to adapt and validate existing HRS network measures and new survey and data collection protocols (molecular
biomarkers, physiological measures) within the KRHDSS; 2) To design Wave 1 of LOSHAK, including a sampling
strategy to draw a regionally-representative probability sample; and 3) To develop a long-term strategic plan for
expansion towards a nationally-representative panel study of aging in Kenya for Wave 2 of LOSHAK. The
KRHDSS platform will enable us to efficiently recruit and enroll participants and will contribute to our success
carrying out these aims. Throughout the infrastructure development process, we will work closely with the HRS
and the HRS Sister Studies Network in order to maximize comparability with the measures and processes (e.g.,
training in HRS interview administration, use of computer-assisted personal interviewing software, data
processing, etc) used in other HRS network studies. Thus, LOSHAK will ultimately provide key population-based
and comprehensive measures on health and economic well-being from mid- to late-life. These data will be
harmonized in order to enable cross-national comparisons with high-income and other low- and middle-income
countries, thereby expanding opportunities to understand health and aging in a global context.

Public health relevance
PROJECT NARRATIVE This project will develop infrastructure for the Longitudinal Study of Health and Ageing in Kenya (LOSHAK). We will pilot test measures and data collection procedures, with a key focus on Alzheimer’s disease and related dementias, mental health, climate change and air pollution, and economic well-being. The infrastructure we develop will enable a future population-based LOSHAK that will be part of the large family of comparable studies around the world on aging, health, and economic well-being in the Health and Retirement Study network.